Role and Function of Peroxisomal Ether Phospholipids in TBI

PROJECT SUMMARY Traumatic brain injury (TBI) is one of the major health concern affecting almost 1.7 million annually in the US. To date no effective therapy is available, mainly because of incomplete understanding of the molecular mechanisms of injury associated biochemical changes in the injured brain. In this study we aim to determine the role and function of ether phospholipids in neurodegeneration after TBI. Ether phospholipids play crucial role in maintaining structural integrity and protecting cellular membrane from oxidative stress. Their synthesis is initiated by the enzyme machinery of peroxisomes. Decreased level of ether phospholipids due to impaired peroxisomal functions have been demonstrated in different neurodegenerative diseases. However, their role in the pathophysiology of TBI has not been assessed. In this study our goal is to test the hypothesis that dysregulation of ether phospholipid abundance due to the impairment in peroxisomal ether phospholipid synthesis contributes to neuronal death after TBI. We will use liquid chromatography mass spectrometry (LC-MS/MS) based lipidomic approach to determine the changes in ether phospholipids in the whole cortical tissues of TBI mice. We will also determine the levels of ether phospholipid precursors in the peroxisomal fractions isolated from mouse cortices after TBI to assess peroxisomal ether phospholipid synthesizing function in the injured cortices. We will also use in vitro neuronal stretch injury model to investigate the mechanisms of dysregulation in ether phospholipid abundance and its role in neuronal death after injury. In AIM 1, we will investigate the mechanisms of dysregulation in ether phospholipid and its role in neuronal death after TBI in mice. LC-MS/MS based lipidomic analysis combined with biochemical methods will be used to test the hypothesis that peroxisomal ether phospholipid synthesis is impaired in the mouse brain after TBI causing decrease in ether phospholipid abundance that contributes to neuronal death in the injured brain. In AIM 2, we will determine the neuroprotective functions of ether phospholipid precursor supplementation in TBI mice. We hypothesize that increase in ether phospholipid abundance will attenuate injury associated neuronal death and will restore motor and cognitive functions in TBI mice. We will treat TBI mice with ether phospholipid precursor ? 1-O-alkyl glycerol and assess its neuroprotective functions by measuring the extent of neuronal death and functional recovery in those mice. Our study will for the first time determine the role and function of ether phospholipids in TBI. We believe that this study will provide new mechanistic insight about TBI associated neuronal death and thus may help us to identify novel therapeutic target to treat TBI.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury (TBI) is one of the major health concern in the US affecting approximately 1.7 million people annually, leading to high mortality, devastating physical and cognitive disabilities among civilian population and military personnel. The aim of our proposed research is to understand the role and functions of ether phospholipids in neurodegeneration following TBI. We will also assess the neuroprotective potential of ether phospholipid precursor treatment in mice after TBI.